PHARMACOLOGIC STUDIES OF MARIJUANA &DELTA 9 THC IN HUMANS

This study is designed to investigate the pharmacological effects of all the combined chemical constituents of the marijuana plant to the effects of the principle psychoactive ingredient, delta-9-THC, alone. The subjective, physiological and behavioral effects of marijuana and delta-9-THC will be compared after administration by the oral route.